Career Enhancement Core

SUMMARY
The overall goal of the Career Enhancement Core of the MS SCORESD is to develop promising
junior faculty into independent, NIH-funded investigators with expertise in sex differences and
women’s health by providing (1) a stimulating, productive mentoring environment, (2) research
assistance and technical training, (3) career development resources, and (4) fiscal and technical
support. A major aim of this program is to foster establishment of independent research programs
by junior faculty members, to train them in how to perform sex differences and women's health
research, if they do not already know, and aid in grant writing and project management. To
achieve this goal, the CEC core will capitalize on the expertise of successful basic, translational,
and clinical investigators at UMMC and the research resources provided by these established
investigators and their laboratories. The CEC will accomplish the goals of the SCORESD by the
following: 1) Develop educational-based programs to instruct investigators in the best practices
for performing sex differences and women’s health research; 2) Recruit experienced faculty to
train and mentor investigators in development of sex differences and women’s health research
programs; 3) Train junior investigators in grant writing skills, and aid in the development of their
specific aims, experimental design and overall grantsmanship as they apply for independent
funding; 4) Manage the Pilot Project Grants program; 5) Assess the progress and success of the
Pilot Project investigators as they obtain preliminary data and extramural funding.

Public health relevance
Career Enhancement Core (CEC) Narrative The overall goal of the Career Enhancement Core of the Mississippi Specialized Center of Research Excellence on Sex Differences is to develop promising junior faculty into independent investigators by providing a stimulating and productive mentoring environment, provide research assistance and training in performance of sex differences and women's health research, and foster career development through training application and support. Research into mechanisms responsible for sex differences in cardiovascular, renal, and metabolic diseases are imperative to find new therapeutic options to improve overall human health, and reduce health care burdens, especially in areas with high cardiovascular disease prevalence, high poverty, low medical care access, low health insurance, such as rural Mississippi and similar areas of the US.